Proteomics Core Facility

PCF is equipped with a Thermo Fisher Lumos mass spectrometer with an nanoflow Ultimate 3000 HPLC, a Thermo Fisher Ascend mass spectrometer with a Vanquish NEO HPLC, and an Agilent 6545XT Advance Bio LC/Q-TOF System.

PCF seeks to provide high quality proteomics services on intact Protein molecular weight measurement; protein identification; protein quantification using label-free or labeled approaches; identification of PTMs including phosphorylation, acetylation, ubiquitination, glutamination and disulfide linkage characterization. PCF also develop methods for unique projects.

PCF staff train users on instrument operation; educate users on mass spectrometry-based techniques; stay informed of new techniques and make them available to PCF users when possible. PCF staff also provide consultation to users and coordinate collaborations.

From 08/2024 to 08/2025, PCF supported more than 30 investigators within and outside NINDS, worked on more than 50 projects, co-authored in 7 papers listed below.

1) Structural basis of fast N-type inactivation in Kv channels.
Tan XF, Fernández-Mariño AI, Li Y, Chang TH, Swartz KJ.
Nature. 2025 Aug 6. doi: 10.1038/s41586-025-09339-7. Online ahead of print.

2) Iron-sulfur clusters in SARS-CoV-2 exoribonuclease and methyltransferase complexes: relevance for viral genome proofreading and capping.
Maio N, Terranova U, Li Y, Bollinger JM Jr, Krebs C, Rouault TA.
Nat Commun. 2025 Aug 15;16(1):7585. doi: 10.1038/s41467-025-62832-5.

3) BCS1L-Associated Disease: 5'-UTR Variant Shifts the Phenotype Towards Axonal Neuropathy.
Orbach R, Maio N, Butterfield RJ, Foley AR, Silverstein S, Li Y, Chao K, Lehky TJ, Potticary A, Rouault TA, Donkervoort S, Bönnemann CG.
Ann Clin Transl Neurol. 2025 Jul 14. doi: 10.1002/acn3.70108. Online ahead of print.

4) DELE1 maintains muscle proteostasis to promote growth and survival in mitochondrial myopathy.
Lin HP, Petersen JD, Gilsrud AJ, Madruga A, D'Silva TM, Huang X, Shammas MK, Randolph NP, Johnson KR, Li Y, Jones DR, Pacold ME, Narendra DP.
EMBO J. 2024 Nov;43(22):5548-5585. doi: 10.1038/s44318-024-00242-x. Epub 2024 Oct 8.

5) Molecular organization of central cholinergic synapses.
Rosenthal JS, Zhang D, Yin J, Long C, Yang G, Li Y, Lu Z, Li WP, Yu Z, Li J, Yuan Q.
Proc Natl Acad Sci U S A. 2025 Apr 29;122(17):e2422173122. doi: 10.1073/pnas.2422173122. Epub 2025 Apr 24.

6) The TMEM132B-GABAA receptor complex controls alcohol actions in the brain.
Wang G, Peng S, Reyes Mendez M, Keramidas A, Castellano D, Wu K, Han W, Tian Q, Dong L, Li Y, Lu W.
Cell. 2024 Nov 14;187(23):6649-6668.e35. doi: 10.1016/j.cell.2024.09.006. Epub 2024 Oct 1.

7) ARMH3 is an ARL5 effector that promotes PI4KB-catalyzed PI4P synthesis at the trans-Golgi network.
Ishida M, Golding AE, Keren-Kaplan T, Li Y, Balla T, Bonifacino JS.
Nat Commun. 2024 Nov 23;15(1):10168. doi: 10.1038/s41467-024-54410-y.